Wildland Urban Interface Exposure Toxicity in Cells, Animals, and Humans

PROJECT SUMMARY
Cloud computing resources have the potential to propel NIH-support research efforts into territories that remain
untapped, and to this day, hold immense promise to change our understanding of human health and the
environment. This supplement proposes to develope the HeAlth Research eNablEd through Cloud ServiceS
(HARNESS) program designed to implement advanced artificial intelligence / machine learning (AI/ML) methods
using a high impact case study on wildfire research. This supplement is developed to support the parent
ONES/R01 award, titled Wildland Urban Interface Exposure Toxicity in Cells, Animals, and Humans'. This
parent award addresses the growing health impacts of wildfires, representing a threat to public health worldwide,
growing in both intensity and prevalence year-by-year. The parent award specifically aimed to incorporate testing
of the toxicological impacts of wildfire events occurring at the wildland urban interface (WUI), culminating in the
burning of both anthropogenic and biogenic materials present in WUI region now facing increased risk of wildfire
events. In the development of this parent award, a database has been cultivated and includes a wide range of
exposure chemistries and toxicological responses (both at the -omics level and phenotypic lung functional level)
associated with variable smoke exposures that can occur during wildfire events. With this database now
developed and organized, we are poised as a team to further incorporate advanced AI/ML methodologies
enhanced through cloud computing resources to better parse exposure-response profiles. This supplement
specifically aims to leverage this starting resource to first develop the HARNESS workflow to be tested in the
NIH Cloud Lab; then assess feasibility and cost-effectiveness of cloud services; and lastly to disseminate
advanced AI/ML techniques and `lessons learned' from incorporating cloud computing into our research example
through our online training resource, the inTelligence And Machine lEarning (TAME) Toolkit. This research effort
will culminate into improved identification of chemical drivers, underlying disease mechanisms and resulting
health outcomes of wildfire-associated exposure scenarios while enabling NIH researchers to more easily
incorporate cloud-based resources into their everday research questions.

Public health relevance
PROJECT NARRATIVE Cloud computing services are now poised to aid and facilitate high impact data storage, analysis, and integration efforts across biomedical research teams, though they remain underutilized due to a lack of tangible use case examples and user-friendly training dissemination. This proposal seeks to address this limitation by developing and launching the HeAlth Research eNablEd through Cloud ServiceS (HARNESS) program leveraging high impact data associated with our parent ONES/R01 on wildfire smoke health impacts, including those occurring at the wildland urban interface (WUI). This supplement will develop the HARNESS workflow using cloud services, test these services using a suite of advanced artificial intelligence and machine learning methods, and disseminate training and lessons learned to enhance overall usage of the cloud in NIH research.